Emergence, stability, and predictors of anxiety in Fragile X syndrome

PROJECT SUMMARY/ABSTRACT
Anxiety is the most common pediatric mental health problem, affecting ~10% of children and adolescents1.
Given the substantial prevalence and impact of anxiety, recent interest has focused on characterizing anxiety
within high-anxiety-risk clinical subgroups (e.g., neurodevelopmental disorders) to provide critical insight into
the specific risk factors, developmental pathways, and consequences of anxiety. Individuals with fragile X
syndrome (FXS) constitute one such high-anxiety-risk subgroup, with up to ~80% of adolescents and adults
meeting criteria for at least one anxiety disorder16. Work from our initial NIMH-funded R01 demonstrated that
anxiety emerges early in childhood in FXS, with 39% of preschoolers diagnosed with at least one anxiety
disorder17, and increases in severity across early childhood. The first funding period of this R01 (2016-2023)
was highly successful (26 papers to date) in characterizing the emergence, stability, and prevalence of anxiety
longitudinally across early childhood (3, 4, and 5-7 years) in children with FXS contrasted to children with
idiopathic (i.e., non-syndromic) autism spectrum disorder (nsASD) and neurotypical (NT) children. However,
this work has fueled a new set of questions regarding the developmental trajectory of anxiety symptoms and
diagnoses from early to middle childhood in FXS which are crucial to identifying the stability and consequences
of anxiety in FXS across critical early developmental periods when intervention is known to be most effective.
To address these gaps, this competitive renewal application will leverage our existing, rich, multidimensional
longitudinal dataset and follow our existing cohort of children with FXS, children with nsASD, and NT children
through 8-10 years, as well as recruit a new large cross-sectional cohort of 8-to-10-year-olds. The specific
aims are to (1) Determine change in anxiety symptoms and diagnoses from 3-10 years of age in FXS
contrasted to children with nsASD and NT children; (2) Document the extent to which potential early risk
factors predict change in anxiety symptoms and diagnoses in children with FXS contrasted to children with
nsASD and NT children; and (3) Identify (a) rates of anxiety symptoms and diagnoses, (b) functional
impairment associated with anxiety, and (c) sex differences in children with FXS contrasted to children with
nsASD and NT children during middle childhood. This study is innovative in its inclusion of an IQ-matched
nsASD contrast group, which will answer critical questions on syndrome specificity and amplify our impact by
generating knowledge on the development, predictors, and consequences of anxiety in children with nsASD
and intellectual disability. This work is significant in that it will greatly expand our understanding of anxiety in
FXS by providing critical information about the developmental course, predictors, and consequences of
childhood anxiety, which will inform the timing and targets of intervention that will improve quality of life for
children with FXS and their families.

Public health relevance
PROJECT NARRATIVE This competitive renewal application aims to provide critical insight into the specific risk factors, developmental pathways, and consequences of anxiety in children with fragile X syndrome (FXS) in comparison to children with non-syndrome autism spectrum disorder (nsASD) and neurotypical development (NT). Following work initiated during the first funding period (2016-2023), characterization of the emergence, stability, and predictors of anxiety during preschool (3-7 years) will be extended to one timepoint during middle childhood (8-10 years), a critical developmental period when anxiety symptoms are likely to become more impairing and intervention is known to be most effective. This work will significantly inform targeted treatments that will improve the quality of life of individuals with neurodevelopmental disorders and their families.